ASSESSMENT OF CORTICOTROPIN RELEASING FACTOR IN CUSHING'S SYNDROME

The purpose of this study is to determine the secretion levels of the pituitary hormone ACTH, the adrenal hormone cortisol, and the hypothalamic hormone corticotropin-releasing factor (CRF) under basal conditions and in response to low and high dose dexamethasone (Decadron) stimulation.